Administrative Core

Core C: Administrative Core The Administrative Core will provide support for the Program Director in coordinating the overall Program Project Grant on a day-to-day basis. The specific responsibilities of the Administrative Core include: [1] overseeing the distribution of scientific core resources to the four individual research projects; [2] managing the weekly PPG Seminars including scheduling, arranging for travel and itineraries for visiting outside speakers; [3] developing and maintaining a website for the PPG to permit outside investigators access to services and reagents developed through this PPG; [4] preparing annual budget reports as required by the University of Michigan and the National Institutes of Health; [5] organizing the Program review by the External Advisory Board and the Internal Advisory Board; [6] overall post-award management including fiscal oversight and assurance of compliance with NIH guidelines.